Functional dissection of the regulatory network that governs cardiomyocyte maturation

ABSTRACT
Between birth and adulthood, cardiomyocytes (CMs) undergo profound changes in size, ultrastructure,
metabolism, and gene expression, a process collectively referred to as CM maturation. Although highly
coordinated, the transcriptional network that governs this process is not understood. This lack of understanding
is a barrier to cardiac regenerative medicine, where our current inability to mature CMs differentiated from non-
myocytes limits their use for disease modeling or replacement therapy. In addition, disruption of maturation by
abnormal hemodynamic loads in neonates who have undergone surgery to correct congenital heart defects
likely contributes to their high incidence of heart failure in adulthood. A sound understanding of the regulatory
network governing CM maturation will inspire hypothesis driven attempts to surmount these challenges.
In mice, a key hallmark of CM maturation is sarcomere isoform switching, including the well documented
neonatal switch from Myosin Heavy Chain 7 (Myh7) to Myosin Heavy Chain 6 (Myh6). We have conducted and
validated an in vivo high throughput CRISPR screen for transcriptional regulators of CM maturation, using the
Myh7/6 isoform switch as the readout. Two top candidates from this screen, Rnf20 and Rnf40, form a complex
which governs deposition of the poorly understood chromatin modification histone-2B mono-ubiquitination
(H2Bub1). H2Bub1 function is unexplored in the heart, and associated with congenital heart disease mutations
in human patients. Therefore, In Aim 1 we will perform a detailed characterization of the impact of Rnf20/40 on
genetic regulation of CM maturation.
A major reason why the transcriptional networks controlling CM maturation are poorly understood is
that appropriate tools were previously unavailable. In this proposal we will utilize a suite of novel in vivo tools to
begin mapping the transcriptional regulatory networks that govern CM maturation. In Aim 2 we will seek to
accomplish this goal by dissecting two Myh7 cis-regulatory elements. Furthermore, we will contrast the genetic
regulation of CM maturation with pathological hypertrophy by discovering and describing the key regulatory
mechanisms of Myh7, which is deactivated during maturation and re-activated in response to pathological
stress. These experiments will yield mechanistic clues as to how gene expression is coordinately controlled
during maturation and disease, thus enabling improved CM production protocols and targeted therapies.
Collectively these experiments will begin to map the transcriptional regulatory network that governs maturation
by defining the functions of select trans-acting regulators and cis-regulatory elements.

Public health relevance
PROJECT NARRATIVE A thorough understanding of the regulatory networks that govern cardiomyocyte maturation is essential for development of successful regenerative strategies and targeted molecular therapies. The goal of this project is to functionally characterize select factors and cis-regulatory elements within these networks.